NIH NATIONAL BRAIN AND TISSUE REPOSITORYPERIOD OF PERFORMANCE: 09/01/2019 - 08/31/2021 (UNCHANGED)TOTAL CONTRACT AMOUNT: $4,937,543.50 (UNCHANGED)TOTAL OBLIGATED AMOUNT: $4,937,543.50 (UNCHANGED)

The NIH Blueprint for Neuroscience Research aims to accelerate transformative discoveries in brain function in health, aging, and disease. Blueprint is a collaborative framework that includes the NIH Office of the Director together with NIH Institutes and Centers that support research on the nervous system. By pooling resources and expertise, Blueprint identifies cross-cutting areas of research and confronts challenges too large for any single Institute or Center. Since its inception in 2004, Blueprint has supported the development of new research tools, training opportunities, and resources to assist neuroscientists.

In addition to supporting cross-cutting neuroscience activities like research training, workforce diversity, and therapeutic development, Blueprint also funds research initiatives. Topics have ranged from transforming our understanding of dynamic neuroimmune interactions to enhancing our fundamental knowledge of interoception, supporting the development of innovative tools and technologies to monitor and manipulate biomolecular condensates, and more. To learn about both current and past areas of research, visit the Blueprint Research Initiatives page.